Mother-Child Dynamics in the Transmission of Social Anxiety: The Roles of Maternal Verbal Communication and Child Attention

PROJECT SUMMARY
Maternal social anxiety is associated with child social anxiety, suggesting that mothers transmit social anxiety
to their children. One pathway to explain this transmission is through children’s social learning from their
mothers. Late childhood is an important period for the onset of social anxiety and social anxiety emerging
during this period is associated with adverse life outcomes. Thus, there is critical need to understand the social
processes through which children acquire social anxiety from their mothers during this period. Children may
acquire social anxiety as a result of attending to their mothers’ negative verbal communication regarding social
situations. Our preliminary findings provided support for this hypothesis showing that maternal negative verbal
communication mediates the transmission of social fear from mothers to children. However, how maternal
social anxiety shapes the moment-to-moment dynamics of mother-child communication regarding fear-relevant
stimuli is largely unknown. More socially anxious mothers may transmit social anxiety to their children through
negative verbal communication and/or by facilitating a rigid dyadic interaction pattern during which children
attend to negative social input for extensive durations. This project’s aims are to (a) examine whether maternal
negative verbal communication mediates the influence of maternal social anxiety on children’s laboratory-
based social fear, (b) examine whether mother-child dyadic rigidity (i.e., perseveration in child attending to
negative maternal input) mediates the influence of maternal social anxiety on children’s laboratory-based social
fear, (c) examine the mediating roles of maternal negative verbal communication and dyadic rigidity in the
association between maternal social anxiety and child social anxiety 6 months later. One hundred 9-12-year-
old children and their mothers will participate in one laboratory visit and complete questionnaires 2-weeks
before and 6 months after this visit. During the visit, dyads will complete a mother-child social interaction task
during which mothers will talk about two hypothetical peers with their children. Prior to this task, mothers will
receive positive information regarding one peer and negative information regarding the other peer. Mothers will
be instructed to show the pictures of these peers during conversations. Child participants will wear comfortable
mobile eye-tracking glasses and their visual attention to the two peer pictures and their mother’s face will be
tracked during the conversations. Child attention to maternal positive and negative social input will be
examined using a dynamic systems method (i.e., state space grids). Upon completion of this project, I will have
tested two possible mechanisms by which mothers may transmit social anxiety to their children. The proposed
study will make a significant contribution to the scientific knowledge on how mothers transfer social anxiety to
their children and may provide a novel target for family-based interventions. I will also receive in-depth training
in (a) theories and methods of dynamic systems approaches, (b) use of mobile eye-tracking in the context of
dynamic social interactions and (c) interventions used in the prevention of childhood anxiety problems.

Public health relevance
PROJECT NARRATIVE Mother-child social interactions play an important role in the mother-to-child transmission of social anxiety; however, the dynamic social processes through which children acquire social anxiety from their mothers are not fully understood. In the proposed project, we will examine the following hypotheses: 1) higher levels of negative maternal verbal communication regarding social situations will mediate the influence of maternal social anxiety on children’s laboratory-based social fear, 2) greater mother-child dyadic rigidity characterized by perseveration in the state of child attending to negative maternal input will mediate the influence of maternal social anxiety on children’s laboratory-based social fear, and 3) more negative maternal verbal communication and dyadic rigidity will mediate the positive association between maternal social anxiety and child social anxiety 6 months later. Findings from this project will provide insight into the dynamic social processes by which mothers transfer social anxiety to their children and identify potential targets for intervention efforts aimed at preventing childhood social anxiety.